Biosynthesis of marine terpenoid natural products

Project Summary / Abstract
Natural product leads from marine life continue to inspire new drugs, with nine approved for clinical use since
2010. A historical challenge with developing marine organism-derived bioactive chemicals has been one of
limited supply. Often, natural drug leads are isolated from rare or environmentally sensitive marine invertebrates
and algae, which challenges the pre-clinical evaluation of promising candidates when demands outweigh natural
supplies. Some terrestrial plant-derived drugs can now be produced in genetically engineered microbial cell
factories, an approach that would be attractive for marine-derived molecules. However, the biosynthetic
machinery responsible for the biosynthesis of bioactive natural products in marine animals and algae is largely
unknown. Until now. We have discovered and validated the first steps of biosynthetic pathways in corals and
algae that lead to over 6,000 terpenoids, including the anti-inflammatory pseudopterosin and anticancer
halomon. We propose a multidisciplinary project to investigate the molecular basis of terpenoid diversification in
marine eukaryotes that harbor terpenoids with promising biological properties. Significant outcomes of this
research project will include a new paradigm for terpenoid biosynthetic logic in marine eukaryotes, and the
application of this basic knowledge toward the microbial production of marine animal and algal molecules. We
propose three specific aims, namely: 1) To develop a marine eukaryotic genome mining platform for algae and
corals; 2) To functionally characterize marine eukaryotic terpene synthases for high yield terpene production;
and 3) To discover and characterize terpene tailoring enzymes (halogenation/oxygenation) associated with
bioactive coral and algal natural products.

Public health relevance
Public Health Relevance Statement Natural product compounds occupy a central role in medicine in providing lifesaving drugs. Supply challenges however often constrain the biomedical potential of promising bioactive natural products from rare or environmentally sensitive marine organisms. Our discovery of the first terpenoid biosynthesis genes in marine animals and amongst the first in marine algae towards flagship bioactive molecules like the anti-inflammatory pseudodopterosin and anticancer halomon offers a path to bioengineering drug leads from marine organisms from sustainable laboratory microbial fermentation.